Methylomic and metabolomic determinants of Lung Function in Asthmatics

PROJECT SUMMARY/ABSTRACT
Asthma progression is associated with reduced growth and an increased decline in lung function (LF) that is
thought to arise from a complex interplay of genes and environment. While several asthma genetic risk loci have
been identified to-date, an in-depth utilization of how environmental factors interact with these loci remains
limited. The methylome and the metabolome are both heavily influenced by the environment and recent studies
confirm a link between both omes. Integrating DNA methylation with the metabolome could be a powerful
approach to obtain converging evidence of specific pathways influencing asthmatic lung function trajectories at
the genome-wide level. While previous studies have investigated the role of the metabolome or methylome with
regard to lung function, none have investigated both “omes” simultaneously for lung function outcomes in
asthmatics. The central hypothesis of this proposal is that DNA methylation (CpG sites) plays a critical
role in modulating downstream metabolites and thus metabolic pathways, some of which may be driven
by an underlying genetic effect on lung function in children with asthma. We want to specifically investigate
multi-omic data from Wnt, Hippo and sphingolipid pathways, known to affect asthmatic lung function generally
and in our preliminary data. We capitalize on the genetic, methylomic and metabolomic data generated from
three large prospective childhood cohorts including two from the Trans-omics for Precision Medicine (TOPMed)
consortium: Childhood Asthma Management Program (CAMP) and The Genetic Epidemiology of Asthma in
Costa Rica (GECRA) study and an independent cohort: The Vitamin D Antenatal Asthma Reduction Trial
(VDAART). This study seeks to integrate multiple omics using innovative and state-of-the-art methodologies:
quantitative trait loci (QTL) mapping to identify genome-methylome associations with LF (Aim 1), QTL mapping
and causal inference testing to evaluate methylome-metabolome associations with LF (Aim 2), correlation-based
network methods to identify a highly correlated set of omic-driven biomarkers in dysregulated pathways (Aim 3).
Priyadarshini Kachroo, PhD, MS is a bioinformatician whose long-term career goal is to transition towards
becoming an independent data scientist with expertise in utilizing multi-omic approaches to complex disease
phenotypes. As Dr. Kachroo completes these aims, her career development plan will support her training goals:
1) deepen clinical understanding of asthmatic LF phenotypes; 2) expand on the statistical skills including causal
inference testing 3) develop skill-set of network methods for integrating multi-omic datasets 4) enhance skills in
study-design, mentorship and the ethics of scientific conduct and communication of research. Dr. Kachroo’s
strong quantitative and methodological background well position her to accomplish these goals, complete the
aims of this proposal and prepare her for an independent research career. The support of a diverse and world-
class mentoring and advisory team in the Channing Division of Network Medicine at Brigham and Women’s
Hospital and Harvard Medical School complement the research areas and ensure success of this proposal.

Public health relevance
PROJECT NARRATIVE Lung function is an important determinant of asthma, a disease with significantly increasing public health burden world-wide. This K99/R00 grant utilizes innovative analytic approach for multi-omic integration of metabolomic, methylomic and genetic drivers of sub-optimal lung function in asthmatic children; none of the studies so far have interrogated their joint role for lung function in asthmatics. The findings from this proposal will provide a better understanding of the mediated effects through multi-omic profiles for asthma pathogenesis and allow us to focus on the molecular intersection of potential biomarkers with predictive potential in dysregulated pathways and life- course interventions for individuals with asthma.